LC-MS System to Determine the Molecular Mass of Synthesized Heparan and Chondroitin Sulfate Oligosaccharides

This fast-track STTR application proposes to synthesize structurally defined heparan sulfate and chondroitin sulfate oligosaccharides for biological research. Glycan Therapeutics is a biotech company specialized in synthesizing sulfated carbohydrates using innovative enzyme-based methods. This proposal is focused on the synthesis of large authentic oligosaccharides in the size range of 10-mers to 16-mers, as well as ultra-large click oligosaccharides in the size range of 30 saccharide residue long. A highly experienced research team, including Dr. Yongmei Xu (University of North Carolina), Dr. Robert Linhardt (Rensselaer Polytechnic Institute), and Dr. Vijay Pagadala (Glycan Therapeutics), will carry out the study. Heparan sulfate and chondroitin sulfate are members of the glycosaminoglycan family present in large quantities on mammalian cell surfaces and in the extracellular matrix, displaying a wide range of biological functions. This proposal is designed to serve two purposes: (i) to develop a reliable and cost-effective method to synthesize structurally defined heparan sulfate and chondroitin sulfate oligosaccharides and structurally controlled polysaccharides to support glycoscience research; and (ii) to simplify this technology to allow nonglycoscientists to utilize this technology in a standard biochemistry laboratory setting. We anticipate that this proposal will provide valuable technical advances to glycoscience research. Three specific aims are proposed: Aim 1 is to synthesize a library of structurally defined heparan sulfate oligosaccharides with a size of up to hexadecasaccharides (16-mers); Aim 2 is to develop novel chemoenzymatic methods to synthesize chondroitin sulfate oligosaccharides; Aim 3 is to prepare structurally controlled click heparan sulfates and chondroitin sulfate oligosaccharides.

Public health relevance
The purpose of this supplementary application is to request funding to purchase a pre- owned LC-MS system at the total cost of $119,500. This instrument will be utilized to determine the molecular mass of the synthesized heparan sulfate and chondroitin sulfate oligosaccharides. The project for the synthesis of heparan sulfate and chondroitin sulfate is currently under the support of NIGMS STTR grant (Dr. Yongmei Xu, 1R42GM128484-02). The LC-MS instrument will allow us to analyze the synthesized oligosaccharides during the reaction, avoiding the purification and desalting steps. This capability will significantly increase our speed and throughput for the sample analysis, which is extremely important for completing the proposed oligosaccharide library synthesis.